Administrative Core

The Administrative Core, consisting of the Center Director and an Administrative Coordinator, will continue to provide support for the mechanisms of evaluation, meetings, and communications that constitute the Center's means of enhancing scientific productivity, establishing collaborative endeavors and maintaining quality control, ease of access and accountability of the core services.